Development of CM-HZ01 as a non-alpha-IL2 therapeutic for the treatment of metastatic melanoma

Summary
Melanoma incidence is increasing at an alarming rate; as the deadliest of all skin cancers, it is estimated that
one person, every hour of every day, dies of melanoma. Interleukin-2 (IL-2) was the first effective cancer
immunotherapy, approved for metastatic renal cancer in 1992 and metastatic melanoma in 1998. IL-2 plays a
central role in suppressing or activating lymphocyte responses through differential binding to IL-2 receptors
expressed on regulatory T-cells or CD8 cytotoxic T-cells, and NK cells, respectively. Engineering selective IL-2
activity, however, has posed a significant challenge for generating effective immunotherapies lacking substantial
toxicity. We are developing CM-HZ01 as a high avidity IL-2 super-agonist that preferentially promotes CD8
effector T-cell expansion and improves anti-tumor activity. In this Direct to Phase II application, we seek to
advance CM-HZ01 to IND for metastatic melanoma, providing a best-in-class therapeutic for patients with limited
effective treatment options.

Public health relevance
Project Narrative Melanoma incidence is increasing at an alarming rate; as the deadliest of all skin cancers, it is estimated that one person, every hour of every day, dies of melanoma. In this Direct to Phase II application, we seek to advance CM-HZ01 to IND for metastatic melanoma, providing a best-in-class therapeutic for patients with limited effective treatment options.